Examining basolateral amygdala function in the development of inhibitory associations

When learning about rewards in our environment, we learn that certain cues come to predict the presence of
particular rewards. This allows us to make decisions about where to exert effort based on the type of reward that
may be available. We are also able to learn when specific cues predict the absence of a particular reward, which
allows for flexible, adaptive decision making. Allocation of time and energy resources can be directed away from
rewards that are unavailable and toward rewards that are more likely to be available. The ability to use stimuli in
the environment to guide behavior towards the most advantageous options is critical and often impaired in disease
states, including substance use disorder. Associations that predict the absence of reward are prevalent but
understudied. This limits our understanding of the basic scientific principles of learning and prevents a complete
understanding of how impairments in this kind of learning emerge in disease states like substance use disorder.
Therefore, the broad goal of this project is to reveal the neuronal mechanisms by which inhibitory reward
associations are established.
Accumulating evidence suggests that the basolateral amygdala helps us to learn that cues in the environment
predict specific available awards, so-called outcome-specific reward memories. The basolateral amygdala is critical
for the encoding and retrieval of such cue-reward memories. Whether the basolateral amygdala also helps us learn
when specific rewards will not be available is unknown, but plausible given evidence that is involved in learning
inhibitory aversive associations. I will ask whether the basolateral amygdala is involved in encoding the inhibitory
appetitive associations and, if so, whether such associations are uniquely linked to a particular outcome. My
hypothesis that the basolateral amygdala encodes identity-specific inhibitory reward memories to support adaptive
decision making. In Aim 1, I will determine the temporal dynamics of basolateral amygdala activity during the
development of inhibitory associations. In Aim 2, I will determine whether basolateral amygdala activity is necessary
and sufficient for the encoding of these associations. Evidence from our lab implicates projections from the lateral
orbitofrontal cortex to the basolateral amygdala in helping us learn when specific rewards are available. Therefore,
in Aim 3, I will examine whether lateral orbitofrontal cortex projections to the basolateral amygdala are necessary
for basolateral amygdala encoding of inhibitory reward associations. The resulting findings, whether for or against
my hypothesis, will provide novel information about the basolateral amygdala and its function. This will facilitate
future work mapping the circuitry that is important for encoding inhibitory associations. I will conduct this project in
the Wassum Lab at UCLA, with the guidance of a remarkable mentoring team. This environment will provide me
with exceptional intellectual and technical training in systems and behavioral neuroscience, fully preparing me for
an independent research career studying inhibitory control over behaviors.

Public health relevance
Learning when rewards are not available allows for adaptive decision making, as time and energy can be redirected towards available rewards. Such learning and subsequent decision making are impaired in disease states, including substance use disorder, though the precise mechanism of this is unknown. This project will evaluate the neural systems involved in the formation of inhibitory associations and how these associations guide choice behavior.